ACCORD Administrative Core

The overall goal of the Administrative Core of the Center for Biomedical Research Excellence (COBRE)
Appalachian Center for Cellular transport in Obesity Related Disorders (ACCORD) at the Marshall University
School of Medicine (MUSOM) is to provide administrative oversight for the career development of ACCORD
investigators as well as growth and sustainability of Center infrastructure. We envision the creation of a
national center of excellence to promote cellular transport physiology in obesity related disorders at MUSOM,
as this institution is at the epicenter of the obesity epidemic of this region. The emphasis of biomedical
research will be on cellular and molecular transport abnormalities in obesity associated conditions such as
dyslipidemia, hypertension, certain tumors and developmental disabilities. A comprehensive plan for
administrative, fiscal, and scientific support will be established and implemented to assure appropriate
supervision and direction of ACCORD. A robust plan for individual and group mentoring will be implemented
as a foundational component of this COBRE. Mentoring will encompass all aspects of development of junior
investigators including, but not limited to, management of lab finances and personnel, meeting individual time-
framed research goals, preparation of manuscripts and presentations, development of extramural grants
including R01 level funding proposals, and any additional individualized needs as identified. The expected
outcome is successful acquisition of R01 NIH funding to sustain and build upon the research foundations that
are already established. To further advance the research capacity, ACCORD will closely interact with existing
resources (e.g., WV INBRE, UK/MU CTSA), and establish new programs. These will include 1. the Biostatistics
and Study Design preCore and Mentoring and Workforce Development preCore that will be grown during
phase I to become a full Cores in Phase II of this COBRE; and, 2. Pilot funding to enhance molecular and
intracellular regulation of cellular transport in obesity related disorders. Finally, formative and summative
evaluation of scientific integrity, progress, and accomplishments of ACCORD will be regularly conducted in a
comprehensive manner. Based on results and advice of the Internal Advisory Committee (including its
Executive Committee) and External Advisory Committee, appropriate corrective steps, as well as prospective
steps to advance the mission of the ACCORD COBRE, will be regularly instituted. With this innovative and
much needed Appalachian region program, we will train the next generation of investigators to conduct cellular
transport research in obesity which contributes to much of the health care disparities not only in WV, but also in
many other regions of this country.